Biostatistics and Bioinformatics Core (BBC)

CORE 3 - BIOSTATISTICS AND BIOINFORMATICS CORE: SUMMARY
The overarching goal of the ELEVATE program project grant (PPG) is to leverage molecular abnormalities in
hepatocellular carcinoma (HCC) to develop novel and effective therapeutic combinations, especially targeting
NASH-HCC. The overarching goal of Core 3 (the Biostatistics and Bioinformatics Core [BBC]) is to promote
excellence in the basic science research and pre-clinical translational research proposed in the PPG
application by providing dedicated and outstanding consultation and collaborative support and expertise in
biostatistics, bioinformatics, and research data management for ELEVATE Projects 1-4, Core 1 (Administrative
Core), and Core 2 (Mouse Models and Pathological Analysis Core), and as needed.
The biostatistics component will provide expertise in experimental design, statistical analysis, and inference for
all experimental studies across all four Projects, the Administrative Core, and Core 2. Support for biostatistical
assistance is proposed to address issues of 1) experimental design; 2) data analysis and the interpretation and
reporting of results; 3) quality assurance of data; and 4) the application of proper statistical methodology.
Biostatisticians will provide support in the statistical aspects of study design, including adequate sample size
requirements and appropriate design layouts for making valid inferences for specified research hypotheses;
collaborate with Project Leaders in data analysis and data summarization; consult with investigators and other
Core facilities on statistical issues; and assist investigators in the preparation of abstracts, presentations, and
manuscripts. The biostatistics team draws its strength from the biostatistics faculty and staff with many years of
collaboration with the ELEVATE investigators.
The bioinformatics component will provide support in genomic data analysis. The bioinformatics personnel
comprise bioinformaticians with expertise in managing, analyzing, and interpreting large-scale genomic
studies, including the analysis of high-throughput sequencing datasets proposed in the PPG. The
Bioinformatics team has a record of collaboration with ELEVATE investigators. In supporting the Administrative
Core and the PPG overall, the BBC will provide support for integrating clinical and laboratory data to enhance
data sharing among ELEVATE investigators and to ensure reproducibility and timely dissemination of high-
quality data.

Public health relevance
CORE 3 - BIOSTATISTICS AND BIOINFORMATICS CORE: NARRATIVE The Biostatistics and Bioinformatics Core (Core 3) will provide dedicated expertise and cost-efficient support in biostatistics, bioinformatics, and research data management for the ELEVATE Program Project Grant P01 application. This core is critical for the ELEVATE program to achieve its overarching research goals of 1) interrogating molecular mechanisms regulating non-alcoholic steatohepatitis (NASH)-hepatocellular carcinoma (HCC) and development of novel combinatorial treatment approaches based on the identified molecular abnormalities, 2) evaluating approaches that improve the efficacy of approved immunotherapy using an authentic NASH-HCC mouse model, and 3) developing novel approaches that engage the immune system to counteract HCC.